Molecular Oncology Program

Molecular Oncology Program: Summary/Abstract
The goal of the HDFCCC Molecular Oncology Program (MO) is to discover, develop, and translate novel
preventive and therapeutic strategies and biomarkers. This is done through research that spans from basic
science at the bench and computer to clinical applications and back, and by focusing on bridging the gap
between scientists and clinical researchers, and from bench to start-up company to bedside. All MO Program
activities reflect the HDFCCC’s cross-cutting themes of Impactful Discovery (Theme 1), Effective Translation
(Theme 2), and Implementation and Dissemination (Theme 3) and are bolstered by the resources and
collaborative environment provided by the HDFCCC. MO is a new research program since the prior competing
renewal. The Center-wide realignment of research programs now allows MO members to interact around
diagnostics and therapies focused on signaling pathways and epigenetics, as well as on therapies that are
mutation-directed but tissue-agnostic, thus spanning multiple disciplines and connecting clinicians,
epidemiologists, and basic scientists. Specifically, MO member research focuses on (1) studying the impact of
genetics on cancer susceptibility, progression, and therapeutic response; (2) modulating signaling pathways for
therapeutic benefit; and (3) developing tools and technologies to dissect tumor and host environment networks.